T cell Epitope Discovery in Sarcoidosis

Project Summary
Sarcoidosis is a systemic granulomatous disorder of unknown etiology that affects the lung in greater than 90%
of cases. The disease is characterized by the accumulation of activated CD4+ T cells in the lung and other sites
of disease activity. Evidence suggests that these T cells are intimately involved in the pathogenesis of
sarcoidosis. In the previous version of this proposal, we identified lung CD4+ T cells from HLA-DR3-expressing
Löfgren’s syndrome (LS) subjects expressing related T cell receptors (TCRs) and determined that these TCRs
recognized peptides derived from NAD-dependent protein deacetylase (NDPD) expressed in a common airborne
mold species, Aspergillus nidulans. Using HLA-DR3-NDPD tetramers and IFN-γ ELISPOT, we validated those
findings and showed that a significantly greater number of NDPD-responsive CD4+ T cells exists in the lungs of
LS subjects; thus,we have identified a potential causative agent in the genesis of LS. This study of Swedish
subjects with LS serves as a “proof of concept” for the current renewal whose focus is to identify T cell epitopes
for CD4+ T cells derived from the lungs of sarcoidosis subjects expressing HLA-DRB1*11:01, the HLA allele
strongly linked to sarcoidosis in Caucasians and African-Americans in the US. Thus, we hypothesize that
expanded CD4+ T cells in the lungs of HLA-DRB1*11:01-expressing US sarcoidosis patients are
accumulating in response to etiologic sarcoidosis antigen(s) and recognize those antigens in an HLA-
DRB1*11:01-restricted fashion. This proposal harnesses the strengths of a multidisciplinary research team
and focuses on a sarcoidosis cohort in the US. Using a single cell RT-PCR approach, Aim 1 will characterize
αβTCR pairs expressed on CD4+ T cells derived from the lungs of US sarcoidosis patients and generate
hybridomas expressing disease-relevant TCRs. The second specific aim will determine the peptides that
stimulate the CD4+ T cell hybridomas expressing the TCRs of interest. The final aim will use functional assays
and HLA-DR11-peptide tetramers to identify and enumerate antigen-specific CD4+ T cells in the lungs of
sarcoidosis patients and determine if the frequency of these T cells can serve as a biomarker for diagnosis and/or
prognosis. Thus, using a novel yet proven scientific approach, we will address critical knowledge gaps in the
etiologic T cell antigens involved in the pathogenesis of sarcoidosis in US patients, further advancing our
understanding of this enigmatic disease.

Public health relevance
Project Narrative It is clear that new approaches for the detection of the etiologic antigen(s) in sarcoidosis are needed. Using bronchoalveolar lavage cells from sarcoidosis patients from the United States, this proposal will extend our current level of understanding of the role of CD4+ T cells in the initiation and progression of sarcoidosis. The identification of sarcoidosis antigens could lead to earlier diagnosis and more directed therapeutic intervention that would directly impact the health of affected individuals.